Delaware INBRE

Project Summary – Administrative Core
The overall mission of the Administrative Core is to bring together the DE-INBRE program effectively achieves
its overall objectives and priorities to further advance Delaware’s impactful biomedical research network, grow
the state’s biomedical research capacity and capabilities, improve outcomes for specific diseases, enhance
diversity, strengthen the workforce, and increase economic activity.
The Administrative Core consists of a leadership team comprised of the DE-INBRE Principal Investigator,
Program Coordinator, and Evaluation Program Director with appropriate administrative support for the execution
of DE-INBRE programmatic activities. In addition to the management of network services and activities, the core
includes an in-depth evaluation program. The External Advisory Committee (EAC) meets twice annually to assist
with the strategic planning and execution of DE-INBRE programs and to provide advice and critiques on the
progress and impact of the DE-INBRE. The EAC, along with the American Association for the Advancement of
Science (AAAS) and an internal evaluation program, provides program evaluation and program enhancement
recommendations. The Steering Committee provides directions of the DE-INBRE program through the identification
of common goals, distribution of resources, establishment of policies and operating procedures, and evaluation
of the impact and effectiveness of the program and network. The Management Team serves as the operational
heart of the DE-INBRE program, collaborating with the Research Development Committee and the scientific
cores—Bioinformatics Core, Centralized Shared Resources Core, Education and Professional Development Core,
and Developmental Research Project Program—to execute supported programmatic activities, including career
enhancement, mentoring, and professional development programs for Pilot Project investigators, faculty, fellows,
and undergraduate and graduate students.
Specific Aims
1. Provide administrative support for the execution of DE-INBRE programmatic activities.
2. Provide career enhancement, mentoring, and professional development programs.
3. Develop and conduct an evaluation plan.